New Chiral Br??nsted Acids for Asymmetric Synthesis

DESCRIPTION (provided by applicant): The vaulted biaryl ligands VANOL and VAPOL form a unique polyborate anion with a boroxinate core and is beginning to be recognized as a very unique and versatile platform for asymmetric catalysis. As an ion-pair with a protonated imine, this chiral anion will effect the aziridination of imines with diazo compounds with very high yields, diastereoselectivity and enanatioselectivity. Mechanistic investigations including natural abundance kinetic isotope studies will be undertaken to understand how the boroxinate catalyst is formed and how it functions in a variety of reactions including aziridination reactions. The boroxinate core is anionic and has seven oxygens which all bear some of the negative charge and it is possible that it serves as a template in which more than one substrate can H-bond with the boroxinate core at the same time and this helps to determine the transition state. Computations will be persued in an effort to understand how the substrates interact with the boroxinate core in the transition state of the aziridination and other reactions. In addition to the unique structure of this boroxinate catalyst, its utility is greatly enhanced by the fact that it can be assembled by the substrate from the ligand, a boron source, two equivalents of an alcohol or phenol and three equivalents of water. The diverse array of catalysts that can be generated by this process is thus virtually limitless. Investigations will also be carried out to determine the effectiveness of this boroxinate catalyst in other reactions including the Darzens reaction, [3+2] cycloadditions, aminoallylation of aldehydes, and the Ugi reaction. PUBLIC HEALTH RELEVANCE: We have discovered the structure of the catalyst-substrate complex for the catalytic asymmetric aziridination reaction of imines (AZ reaction). With the information gained from this structure, the goals of this proposal are to study the mechanism by which these catalyst react, design new catalyst structures for enhanced reactivities and selectivities and to apply them to other organic reactions.

Public health relevance
Project Narrative We have discovered the structure of the catalyst-substrate complex for the catalytic asymmetric aziridination reaction of imines (AZ reaction). With the information gained from this structure, the goals of this proposal are to study the mechanism by which these catalyst react, design new catalyst structures for enhanced reactivities and selectivities and to apply them to other organic reactions.